Development of an Enantiomeric Specific Vaccine for 3,4-Methylenedioxypyrovalerone (MDPV) Abuse

PROJECT SUMMARY/ABSTRACT Synthetic cathinones, often marketed as bath salts, are dangerous psychoactive drugs of abuse which are perceived by users as a safe, legal high. Synthetic cathinones, like 3,4-­methylenedioxypyrovalerone (MDPV), exhibit stimulant effects similar to cocaine and amphetamines;? however, secondary effects can lead to psychosis, cardiovascular toxicity, and death. MDPV is available to drug users as a racemic mixture, but the central nervous system and cardiovascular effects are primarily attributed to the (S)-­enantiomer. While there are currently no vaccines approved for treating substance use disorders in humans, several vaccines to protect against medically dangerous abused substances are in clinical trials. The hypothesis for this project is that an (S)-­MDPV-­conjugate vaccine can mitigate adverse effects of MDPV-­like drugs of abuse. In Aim 1, an (R,S)-­MDPV and (S)-­MDPV vaccine will be investigated for optimal immunochemical and pharmacological characteristics in male and female Sprague Dawley rats. Following immunization, rats will be administered MDPV;? and serum concentrations of MDPV will be determined. Serum will also be characterized for immune response, specificity, and selectivity for (S)-­MDPV-­like cathinones. In Aim 2, the selected MDPV vaccine will be assessed in male and female rats for effectiveness and safety following escalation doses of MDPV using translationally important behavioral and cardiovascular parameters. For determining vaccine-­induced changes in stimulant activity, rat locomotor activity will be measured after administration of MDPV to quantify horizontal and vertical movement. To determine changes in cardiovascular parameters, rats will be implanted with devices that record heart rate, blood pressure, and temperature and challenged with MDPV. In Aim 3, the vaccine will be tested in self-­administration studies to assess the ability to alter the reinforcing effects of MDPV and to evaluate the safety of the vaccine. Results from these studies could significantly improve the design of targeted immunotherapy for the treatment of substance use disorders caused by racemic mixtures. The overall proposal provides advanced training for a translational scientist who is capable of integrating knowledge from analytical chemistry, pharmacokinetics, behavioral sciences, and biological-­based medications to maximize the probability of important discoveries for addressing treatment of cathinone use disorders.

Public health relevance
PROJECT NARRATIVE Synthetic cathinones are medically dangerous drugs of abuse which are sold as “bath salts”, but can cause an array of adverse effects including psychosis, cardiovascular toxicity and death. There are currently no specific treatments for synthetic cathinone use disorders. I propose to develop a drug class-specific vaccine that could potentially block or reduce the effects of some of the most dangerous synthetic cathinones.